Community Outreach and Engagement

COMMUNITY OUTREACH AND ENGAGEMENT – ABSTRACT
Karmanos Cancer Institute (KCI) is the largest cancer research and care network in the state of Michigan.
Headquartered in the city of Detroit, the KCI catchment area covers 46 of Michigan’s 83 counties, an area that
is home to 6.7 million residents. KCI’s mission is to lead in transformative cancer care, research and education
through courage, commitment and compassion. Dr. Hayley Thompson (PSDR), Associate Center Director for
Community Outreach and Engagement, leads KCI’s efforts in support of this mission. Under her leadership, KCI
has expanded its Community Outreach and Engagement (COE) efforts through the Office of Cancer Health
Equity and Community Engagement (OCHECE). OCHECE’s activities are guided by a cancer surveillance
strategy that captures data across four distinct catchment area regions that are diverse across race, ethnicity,
and rurality. Activities are further guided by a participatory research approach in which community stakeholders
are actively engaged in research prioritization, implementation, and dissemination. In 2016, OCHECE worked
with range of community partners to establish Michigan Cancer HealthLink, a network of Cancer Action Councils
(CACs) organized as neighborhood-based and population-driven groups of cancer survivors, caregivers, and
advocates who have been historically excluded from meaningful research collaborations. The CAC infrastructure
has provided a mechanism for community stakeholders to dialogue with researchers and inform the public
relevance of KCI research across the Cancer Center’s four research Programs (Tumor Biology and
Microenvironment, Molecular Imaging, Molecular Therapeutics, and Populations Studies and Disparities
Research). These strategies of surveillance and engagement ensure that KCI research and outreach are
aligned with the cancer burden in the catchment area.